Neural Mechanisms of Categorical Decisions and Learning During Saccade-Based Visual Foraging

Summary and Relevance of Proposed Research
Humans have a remarkable capacity to learn to recognize the significance of visual stimuli. This ability, which
is disrupted by a brain-based diseases and conditions such as Alzheimer’s disease, schizophrenia, stroke, and
attention deficit disorder, is critical because it allows us to learn about the meaning of the stimuli that we
encounter, and it enables us to make appropriate decisions. Our recent work examined the roles of a network
of cortical and subcortical areas to visual category decisions, including posterior parietal cortex (PPC), frontal
eye field (FEF), and superior colliculus (SC). However, those previous studies only examined these regions
after weeks or months of training required to learn the categorization tasks. The long training required to learn
those tasks precluded studying mechanisms by which neural category encoding developed during the learning
process itself. This project develops a novel paradigm for studying rapid within-session category learning using
a saccade-based foraging paradigm which takes advantage of subjects’ innate ability to search among arrays
of visual stimuli with saccades. In this paradigm, subjects are presented with arrays of stimuli belonging to two
or three categories, with each category associated with a different reward amount. Subjects must search or
“forage” among stimuli by making self-guided saccades to obtain the reward associated with each target
image. During foraging-based learning, population recordings will monitor PPC, SC, FEF, and orbitofrontal
cortex (OFC). We will also assess the causal contributions of these regions using reversible inactivation during
task performance. This will determine how interactions between neurons in these regions enable rapid
category learning and transforming category recognition into stimulus selection and saccadic motor plans.
While much is known about how the brain processes visual features (such as color, orientation, and direction
of motion), less is known about how the brain learns and represents the meaning, or category, of stimuli. A
greater understanding of visual categorization is critical for addressing a number of brain diseases and
conditions (e.g. stroke, Alzheimer’s disease, attention deficit disorder, schizophrenia, and stroke) that leave
patients impaired in everyday tasks that require visual learning, recognition and/or evaluating and responding
appropriately to sensory information. The long-term goal of this project is to guide the next generation of
treatments for these brain-based diseases and disorders by helping to develop a detailed understanding of the
brain mechanisms that underlie learning, memory and recognition. These studies also have relevance for
understanding and addressing learning disabilities, such as attention deficit disorder and dyslexia, which affect
a substantial fraction of school age children and young adults. Thus, a detailed understanding of the basic
brain mechanisms of categorical decisions and attention will likely give important insights into the causes and
potential treatments for disorders involving these cognitive and perceptual abilities.

Public health relevance
Project Narrative Our ability to learn to recognize the category, or behavioral significance, of visual stimuli is essential for planning and carrying out successful behaviors in response to our surroundings. This project develops novel behavioral tasks and neuronal population recording approaches for studying the brain basis of rapid reward- based visual category learning during naturalistic foraging paradigm. The work will provide a detailed and mechanistic understanding about how encoding in and interactions between multiple interconnected brain areas mediate rapid learning and decision making, which is critical for understanding and ultimately addressing the profound deficits of learning, memory and decision making that frequently accompany brain diseases and conditions such as stroke, schizophrenia and Alzheimer’s disease.